Nutrient-dependent regulation of neural stem cell proliferation and neural circuit formation

Project Summary/Abstract:
Our brain is composed of an immense diversity of neurons that are molecularly, morphologically, and
functionally distinct. Understanding how this immense diversity of neuron types is generated and
organized to allow us and other adult animals to carry out such a vast array of complex tasks and
behaviors is of great importance. By far, most of the neurons in our adult brains are generated during
development, either directly or indirectly from the cell divisions of a defined but rather heterogeneous
population of neural stem cells. Molecular differences exist among neural stem cells based on their
location and neural stem cells themselves can change their intrinsic genetic programs over time.
Research outlined in this proposal is geared towards better understanding of how neural stem cell
extrinsic factors integrate with neural stem cell intrinsic factors to control numbers and types of neurons
produced through time and space during development.
In the Siegrist lab, we use the genetically tractable model organism, Drosophila melanogaster, to
uncover the genetic pathways and molecular mechanisms regulating neural stem cell proliferation
decisions, from quiescence to proliferation, and then termination once development is complete. Our
research goals include gaining a better understanding of how dietary nutrient availability affects neural
stem cell proliferation decisions. In Drosophila, different neural stem cells respond differently to dietary
nutrient availability. Most enter and exit quiescence in a dietary nutrient- and PI3-kinase-dependent
manner, except for a small subset. The neural stem cells that divide continuously independent of dietary
nutrient availability are the neural stem cells that generate neurons important for memory and learning.
Through genetic and single cell sequencing techniques, we are working to identify the intrinsic
differences among these neural stem cell types that distinguish nutrient-dependence versus nutrient-
independence. We are also working on determining how dietary nutrients consumed during
development regulate neural stem cell temporal programs and thus types and numbers of neurons
produced. Neural stem cells in Drosophila sequentially express a series of transcription factors over time
that specify the neuron types produced at each cell division. Whether extrinsic factors, such as nutrient
availability, affect neuroblast intrinsic temporal programs is currently unknown. Finally, we are also
working to map out the neural circuitry that regulates neural stem cell proliferation decisions in
response to dietary nutrient availability. Altogether, the research outlined here will advance our
understanding of neural stem cell proliferation control during development and how dietary nutrient
availability affects types and numbers of neurons produced. These insights should stimulate new
discoveries in translational stem cell research in the context of normal development and disease states.

Public health relevance
Project Narrative: Neurodevelopmental disorders, including microcephaly and autism, as well as neurodegenerative diseases, including Alzheimer’s, and cancer result in significant human suffering and impose significant annual costs on the US health care system and society as a whole. Neural stem cells are the cells that make all the neurons in the brain, and this proposal seeks to understand how diet influences neural stem cell proliferation decisions during development. Results garnered from this research will stimulate new discoveries in translational stem cell research in the context of normal development and disease states.